Enhancing Sexual Orientation and Gender Identity Data Collection across the Duncan Cancer Center

PROJECT SUMMARY
A poll published in February 2022 reported that 7.1% of US adults self-identify as LGBTQ, up from 4.1% in a
similar poll in 2016. Additionally, the percentage varied by age with 2.6% among Baby Boomers and 20.8% of
Generation Z. The American Cancer Society estimates that there will be more than 1.9 million new cancer
diagnoses in the US in 2022, and more than 600,000 people will die from their cancer. “Back of the envelope”
calculations would, therefore, estimate that 135,000 LGBTQ Americans will be diagnosed with cancer this year
and more than 40,000 will die from their cancer. However, these estimates are not based on empirical data
because cancer registries do not collect data on sexual orientation and gender identity (SOGI). Further, many
cancer centers do not collect these data for clinical or research uses. While studies have shown that certain
cancer risk factors such as alcohol use, tobacco use, obesity, and oncogenic viral infection are more prevalent
amongst SGM individuals, we do not currently have the data to understand the risk factors that are unique among
LGBTQ individuals nor what factors contribute to their cancer survivorship experience. The overarching goal of
this supplement is to use a stakeholder-engaged approach to integrate a SOGI questionnaire in the electronic
medical record at Dan L. Duncan Comprehensive Cancer Center (DLDCCC)-affiliated clinics and evaluate its
feasibility, acceptability, and utilization among patients and providers. We will pursue the following specific aims:
Aim 1: a) To understand contextual barriers and facilitators to routine of SOGI data collection in DLDCCC
hospitals; and b) to use participatory approaches to identify and adapt implementation strategies (i.e., SOGI
training and SGM-inclusive messaging and resources in the healthcare setting) to support the routine collection
of SOGI data in the electronic medical record. Aim 2: a) To determine the rate of SOGI data assessment,
response, and quality after incorporating a SOGI questionnaire in the electronic medical record in DLDCCC
hospitals; and b) to evaluate how these indicators are affected by the implementation of SOGI training and SGM-
inclusive messaging and resources in the clinics. Aim 3: a) To assess the feasibility and acceptability of routine
SOGI data collection among DLDCCC patients, oncology providers, and staff; 2) to assess the feasibility and
acceptability of SOGI training among DLDCCC oncology providers and staff.

Public health relevance
PROJECT NARRATIVE New data show that approximately 7% of US adults self-identify as LGBTQ; accounting for roughly 135,000 newly diagnosed cancer cases each year. Previous studies have reported that certain cancer risk factors such as alcohol use, tobacco use, obesity, and oncogenic viral infections are more prevalent amongst sexual and gender minority (SGM) individuals. However, there is a complete lack of empirical data on the rates of cancer incidence and survivorship in the LGBTQ+ community; there needs to be a push to implement universal data collection on SGMs in cancer centers and registries.